Genetic and Transcriptomic Mechanisms of Progressive Ethanol Consumption in the Diversity Outbred Mouse

Project Abstract
Alcohol use disorder (AUD) poses a global healthcare burden, with significant morbidity and
mortality associated with excessive alcohol consumption and effective therapeutic options still lacking. Human
genome-wide association studies have recently identified genes potentially modulating alcohol consumption,
but pinpointing their mechanisms of action remains difficult. Genetic variance influencing gene expression has
been suggested as an additional factor in AUD but remains difficult to study in humans due to confounding
environmental factors, difficulty with tissue collection and inability to conduct mechanistic manipulations.
Mouse models are an effective substitute; Diversity Outbred (DO) mice from Jackson Labs display a large
amount of genetic diversity and small recombination intervals, allowing for precision mapping of quantitative
trait loci (QTLs). Recent research in our lab using Diversity Outbred (DO) mice identified marked variability in
ethanol consumption, with a pattern of progressive ethanol intake across the DO mice and heritability ranging
from 48-62%. Multiple highly significant or suggestive behavioral quantitative trait loci (bQTL) were identified
for alcohol consumption phenotypes, along with unique positional candidate genes; however, determination of
causal candidates and definition of mechanisms by which specific genes influence ethanol consumption have
not been yet been accomplished. We hypothesize that genetic mechanisms of DO mouse ethanol consumption
variance are largely driven by cognate differences in gene expression networks across PFC and NAc and that
a combined behavioral and expression genetics approach can identify critical molecular mechanisms and
candidate genes modulating ethanol consumption. To test this hypothesis, we aim to 1) employ an algorithm to
rank candidate genes influencing ethanol consumption using RNA-seq data collected from PFC and NAc
samples from DO mice, and functionally characterize gene expression networks associated with ethanol
consumption; 2) derive mechanistic causal inferences about individual gene expression patterns and their
relationships with ethanol consumption, and estimate direct genetic and individual gene transcript mediation
effects using structural equation modeling; and 3) validate causal candidates using viral vector mouse genetic
modulation of a candidate gene for ethanol consumption. These studies will provide the applicant with robust
and unique training in quantitative genetics, genomic and transcriptomic analyses, and the neurobiology of
alcohol, preparing him for a successful career as future independent investigator in the behavioral genetics of
alcohol.

Public health relevance
Project Narrative Alcohol use disorder (AUD) is a major global healthcare burden, but effective therapies are lacking in part due to the complex genetic architecture of alcohol consumption and dependence. A combination of genetic and transcriptomic factors has been proposed as mechanisms underlying variation in alcohol-related behaviors, but these factors are difficult to study in humans due to confounding environmental factors. We hypothesize that by using a novel complex mouse genetic model, we can identify candidate genes and functional pathways which may be involved in the genetic mechanisms affecting ethanol consumption and validate individual candidate genes as potential therapeutic targets by modulating gene expression in a mouse model.